Efficacy of a Healthy Lifestyle Intervention to Prevent Depression in Older Spousally bereaved Adults - Supplement

PROJECT SUMMARY/ABSTRACT
My ongoing research (R01 MH118270) examines the efficacy of a digital health intervention to stabilize the 24-
hour rhythm of sleep, meals, and physical activity for reducing symptoms of depression in acutely-bereaved
older adults. The onset of COVID-19 in 2020 occurred in tandem with the start-up phase of this study. As a
result, I experienced significant setbacks because of the COVID-19 pandemic. First, the recruitment of older
adults was significantly delayed (due to quarantine, social distancing, and participant concerns) and
enrollment did not start until January of 2021 – 17 months into the project period. This delay had cascading
effects on the study timeline and the feasibility of implementing a 15-month study in a newly-truncated project
period. Second, I was an Early-Stage Investigator (ESI) who experienced significant disruptions to the startup
of my independent research lab. Not only did I hire, train, and motivate staff in an uncertain and virtual
working environment, but my reduced level of productivity impacted future milestones in my career trajectory
(e.g., submission of new grants, development of new collaborations, and time to promotion). I exhausted all
other means to overcome COVID-19 setbacks for this study. For instance, I modified the intervention and study
protocol to be 100% contactless and virtual, and I expanded the reach of my intervention to geographic
locations across the United States. Since the start of enrollment in 2021, my study team has enrolled 87% of
our target sample and retained 91% of participants over the 15-month follow-up. I am confident in my team’s
ability to finish this study. However, the parent aims may not be achievable unless I can secure additional
funding to complete follow-up. In this administrative supplement, I propose to use additional funds for partial
salary support for my study staff to complete post-intervention follow-up for 45 individuals. The proposed
supplement aligns with NOT-MH-23 because (1) substantial components of the initial investment are at risk
(e.g., longitudinal data are required for the planned analyses) and (2) I was an ESI implementing my first
substantial research grant from the NIMH. This study is the first of its kind to test the effects of a circadian-
influenced behavioral intervention on reducing depression after the loss of a spouse/life partner – a distressing
albeit common life event in late life. Findings from this study will inform the development of widely
generalizable and scalable technology-based intervention to support bereaved persons in community-based
settings. However, additional funds are necessary to complete the project and collect post-intervention follow-
up data.

Public health relevance
PROJECT NARRATIVE As an Early-Stage Investigator implementing my first R01 during COVID-19, I experienced significant setbacks in terms of my ongoing research (R01 MH 118270) and career trajectory. This Administrative Supplement will permit me to overcome some of those setbacks by allowing me to complete follow-up for 45 individuals and analyzing the parent study aims as planned. Completion of follow-up are critical not only for project success and NIMH’s return on investment but also my career advancement in which I plan to build upon this study and continue to develop behavioral interventions for reducing depression in older adults.